Mucosal Immune Surveillance at the Taste Papillae

Project Summary
Taste buds are continually exposed to oral and food borne microbes, but the pathways underlying the three-
way interactions between taste cells, the oral microbiome and oral epithelial immune cells have not been
studied in sufficient detail. While the vast majority of the hundreds of microbial species in the oral cavity are
either innocuous or beneficial to the host, dysregulation of the oral microbiome can cause taste disorders.
Infection associated taste loss is observed in the cases of COVID-19, viral hepatitis, influenza, and candidiasis,
to name a few examples. Mucosae such as those in the gut and tonsils possess secondary lymphoid tissues
called mucosae associated lymphoid tissue (MALT) over laid by specialized epithelia call the follicle associated
epithelium (FAE). FAE contain immune surveillance cells called microfold cells (M cells) that transcytose
luminal microbes and present them to immune cells in the underlying germinal centers, that generate an
appropriate immune response. Thus, M cells are central players in mucosal immunity, and dysregulation of M
cell pathways are known to cause infection. Using single cell RNASeq, we discovered that sweet taste receptor
cells (STRCs) and duct cells of the von Ebner gland (VDCs), a minor salivary gland associated with taste
papillae, express several M cell marker genes, including Spib, a transcription factor required for M cell
development and regeneration. These findings were confirmed using RNAScope and double label
immunohistochemistry with STRC and other taste cell type marker genes. Administration of RANKL, a growth
factor required for M cell regeneration led to dramatic upregulation of M cell marker genes in taste papillae
from wild type (WT) but not Spib knock out mice. We hypothesize that STRCs and VDCs participate in immune
surveillance at the taste papillae in the same manner as M cells, and that perturbances in this pathway might
lead to infection, inflammation and taste loss. We will test this hypothesis by thoroughly examining the
expression of M cell marker genes in taste papillae using quantitative polymerase chain reaction, RNASeq and
histological techniques, and by determining the ability of the RANKL to trigger M cell proliferation in specific
pathogen free (SPF) and germ free (GF) WT mice and SPF Spib conditional knockout mice (SpibCKO mice) and
taste organoids cultured from them. We will also determine the changes in immune cell recruitment to the taste
papillae in all three mouse strains/conditions described above. The ability of STRCs and VDCs in vivo and in
taste organoids to transcytose luminal microbes will be measured by quantifying the uptake of fluorescently
tagged nanoparticles and green fluorescent protein expressing Escherichia coli. The changes in taste
sensitivity in SpibCKO mice will be determined using brief access taste test in a gustometer. Our study
represents a novel foray into the intersection between taste biology and immunity and has the potential to
deepen the understanding of mucosal immune surveillance at taste papillae. Successful completion of this
study promises to help design novel strategies to treat taste loss associated with infection, obesity and aging.

Public health relevance
Project narrative We recently discovered that sweet taste receptor cells and duct cells of minor salivary glands associated with taste papillae express marker genes for Microfold cells that mediate microbial transcytosis in secondary lymphoid organs in the gut and tonsils. We will determine their roles in regulating immunity at the taste papillae using knockout mice models, microbial transcytosis assays and taste behavior assays. Our study has the potential to uncover the hitherto unidentified pathways underlying taste cell- oral microbiome interactions and its effects on taste cells in health and disease.